Novel Pharmacological Treatment for Preeclampsia

Novel Pharmacological Treatment for Preeclampsia
Abstract
Preeclampsia (preE) is a serious hypertensive complication of pregnancy often accompanied by proteinuria
and edema, sometimes with encephalopathy, seizures, and hepatic failure. PreE complicates 5 to 10% of
pregnancies and is a major cause of maternal and fetal morbidity and mortality worldwide. Nevertheless, an
effective therapy for this disorder does not exist. There is no known specific treatment, although palliative
measures such as antihypertensive drugs, magnesium, and steroids, and early delivery improve outcomes. H2
relaxin (serelaxin) acts on the G protein-coupled receptor (GPCR), Relaxin Family Peptide Receptor 1 (RXFP1)
to mediate vasodilatory and cardioprotective effects in patients with acute heart failure (AHF). However, the long-
term beneficial effects of serelaxin in AHF are likely related to its strong anti-fibrotic effects that have been shown
in multiple animal models. Recent data suggest that serelaxin may be a promising treatment for preE. Despite
its enormous promise, serelaxin has a short half-life in vivo, is difficult to synthesize, and cross-reacts with the
related receptor, RXFP2. In addition, the cAMP-mediated actions of serelaxin may be associated with deleterious
long-term effects. To address these limitations, we have identified a novel B-chain-only peptide variant of
serelaxin, B7-33, which is RXFP1-specific, ameliorates fibrosis via cell-specific effects on fibroblasts, is less
expensive to manufacture, and as a single chain peptide is also far easier to functionalize to improve its stability
and in vivo efficacy. B7-33 is the first single-chain insulin-like peptide having a selective signaling profile that
favors the anti-fibrotic actions of serelaxin, but with minimal cAMP-related effects. The overall goal of this
project is to develop and characterize B7-33 as an innovative treatment for preE. In Phase 1, we will
demonstrate biological activity of an extended half-life conjugate of B7-33 in cell-based assays and in small
animal models of preE. Demonstration of similar activity as the parent B7-33 and ability to reduce preE syndrome
in the models will merit submission of a Phase 2 application. Phase 2 work will focus on obtaining the preclinical
data necessary for submission of an IND. Pharmacokinetics and toxicity studies, as well as animal studies to
demonstrate efficacy, will be performed.

Public health relevance
Narrative Preeclampsia (preE) is a complication of pregnancy that affects 5-10% of pregnancies and can be life- threatening. PreE patients are given supportive therapy, such as anti-hypertensives and steroids. No specific and effective therapy, other than delivery, exists. Recently, the peptide hormone relaxin has been shown effective in small animal models and safety in human patients. We have identified a novel relaxin analog that will be the first effective treatment of preE.